OPTIC NEURITIS TREATMENT TRIAL

The purpose of this study is to determine the value of corticosteroids in the treatment of optic neuritis, specifically to study the visual functional benefit of treatment with corticosteroids.